Combining Serotonergic Neural Progenitor Transplantation and Exercise to Improve Cardiac Disorders and Autonomic Dysreflexia After Spinal Cord Injury

Project summary
Disruption of supraspinal regulation causes reduced sympathetic and unopposed parasympathetic activity,
leading to cardiac and hemodynamic disorders after high-level spinal cord injury (SCI). We recently reported that
renewal of serotonergic regulation over hemodynamics could be achieved with transplantation of embryonic
raphe nucleus-derived neural progenitors/stem cells (RN-NPCs) in a rat SCI model. It was previously showed
that exercise, a viable therapeutic intervention, heightens neuronal activity, axonal regrowth, and production of
neurotrophic factors after SCI. Accordingly, we posit that transplanting serotonergic NPCs in the injured spinal
cord will reestablish serotonin regulation to improve cardiac function, and combining RN-NPC grafts with
exercise will enhance the recovery of cardiac activity, hemodynamics, and autonomic dysreflexia after SCI. In
Aim 1, we will determine whether integration of transplanted serotonergic NPCs with spinal cord circuitry will
restore sympathetic regulation to improve cardiac electrical conduction following SCI. In Aim 2, we will test
whether combining RN-NPC transplants with exercise will further enhance the reconstitution of sympathetic
modulation to restore cardiac activity, hemodynamics, and autonomic dysreflexia. Overall, this project will
provide novel insight into therapeutic strategy following SCI.

Public health relevance
Narrative A high-level spinal cord injury (SCI) interrupts supraspinal regulation of sympathetic activity to the heart. The imbalance of sympathetic and parasympathetic outflow leads to cardiac and hemodynamic disorders. In this project, we will determine whether integration of transplanted raphe nucleus-derived neural progenitor cells (RN-NPCs) or human induced pluripotent stem cell (iPSC)-derived serotonergic progenitors with spinal cord circuitry reestablishes serotonin regulation to improve cardio-electric transduction. Meanwhile, we will test whether combining RN-NPC transplants with exercise further enhances the reconstruction of sympathetic regulation to restore cardiac activity, hemodynamics, and autonomic dysreflexia after SCI. The results will provide vital guidance to future clinical therapeutics.